FUNCTIONAL MRI INVESTIGATION OF EXECUTIVE FUNCTION PROCESSES IN FXS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Individuals with fragile X syndrome (FXS) differ from control participants in the size and function of many brain areas, including the caudate, thought to be important for motor control, implicit learning and executive function processes. To read about other projects ongoing at the Lucas Center, please visit http://rsl.stanford.edu/ (Lucas Annual Report and ISMRM 2011 Abstracts)